Uncovering a role for S-nitrosylated phospholipase D3 in the microglial and neuronal pathophysiology of Alzheimer's disease

Project Summary/Abstract
Alzheimer’s disease (AD) is an age-related neurodegenerative disease affecting millions of people worldwide.
Its pathological hallmarks include extracellular plaques formed from amyloid beta (Aβ) peptide, dystrophic
neurites containing hyperphosphorylated tau protein, oxidative and nitrosative stress, microglial activation,
severe synapse loss, and neuronal death; the consequence of these changes is progressive dementia.
Attempts to treat AD by targeting Aβ have so far fallen short of addressing the entire pathology, and more
diverse strategies are critical to the pursuit of disease-altering therapies. A promising area of study is the
cellular changes caused by redox processes that affect protein function; one such change is protein S-
nitrosylation, a redox-mediated posttranslational modification whereby nitric oxide (NO)-related species react
with a thiol group (or more properly thiolate anion) on a cysteine residue, a reaction discovered in our
laboratory. S-Nitrosylated proteins (SNO-proteins) undergo structural and functional changes which can be
disease-relevant, although the full import of these changes throughout the proteome is only now beginning to
be explored. In a recent unbiased mass spectrometry study, our group found that S-nitrosylated phospholipase
D3 (SNO-PLD3) is associated with AD in human brain samples compared to controls. This proposal seeks to
elucidate mechanistically the pathological importance of this result to AD. PLD3, a lysosomal 5’ exonuclease
found in many cell types, is involved in regulation of toll-like receptor (TLR)9 innate immune signaling in
macrophages; it is also known to colocalize with Aβ plaque-associated inclusions within dystrophic neurites in
AD mouse models and human AD patients, and single nucleotide polymorphisms in PLD3 confer genetic risk
for AD. My preliminary data show that S-nitrosylation of PLD3 increases its enzymatic activity. In light of these
results, recently-published crystal structure data, and the fact that S-nitrosylation of a cysteine residue can
facilitate disulfide bond formation between vincinal cysteines, I propose to test the hypothesis that S-
nitrosylation of PLD3 facilitates a reversible “signaling” disulfide bond that serves to increase PLD3 stability
and enzymatic activity, thus downregulating TLR9 signaling—which has recently been linked to memory
formation. I will elucidate the effect of S-nitrosylation on PLD3 structure, and then examine the cellular
consequences, including TLR9 dysregulation, in human induced pluripotent stem cell (hiPSC)-derived models
of microglia and neurons. Accordingly, my Specific Aims are to:
1. Determine the effect of S-nitrosylation on PLD3 structure and stability, and
2. Determine the impact of redox-mediated modulation of PLD3 exonuclease function on TLR9 signaling
in microglia and neurons.
Understanding the role of SNO-PLD3 in cellular pathologies may provide a new therapeutic target for AD
involving redox modulation of protein function.

Public health relevance
Project Narrative This proposal takes the finding that S-nitrosylation of phospholipase D3 (SNO-PLD3) is associated with Alzheimer’s disease and aims to explain this result by elucidating the molecular and cellular mechanisms involved. Specifically, this work will explore the consequences of SNO-PLD3 in human induced pluripotent stem cell-derived models of microglia and neurons. The findings from this study will open the door for possible development of new redox-related drug targets for the treatment of Alzheimer’s disease.